Maintenance and Improvement of NINDS Infrastructure

The following laboratories and research support areas underwent planning, modification, relocation, or renovations during FY 2025:
1. Equipment Modifications and renovation Animal Vivarium Facility,Location NIH Bethesda Campus, Bldg 35.
2. Neuroimmuelogy office cluster. Location: NIH Bethesda Campus, Bldg. 10.
3. Surgical Neurology Branch laboratories. Location: NIH Bethesda Campus, Bldg 10.
4. MRI siting evaluation. Location: Bethesda Campus. Bldg 35A.
5. Cell Biology and Biophysics Section. Location: NIH Bethesda Campus, Bldg 35

Minor Projects (SAT), including:
 To connect the building CO2 system to EZ system smartbox
 Completed- To investigate and restore a clogged vacuum line showing weak/non-existent suction power. Location: 35/3C313/315/317.
 Completed - Installing red lights for two room in the animal holding rooms.
 Completed – Install a 240 outlet for an ultracetrifuge
 Completed – To remove a wall partition in the Porter Building.
 Completed – A special outlet for a UPS for a Laser system in the Porter Building.
 Completed – Modify the existing Getinge Steam Sterilizer (Autoclave) to a new control platform in the Porter Building.
 Completed -- Refill glycol to the data central backup unit.Location 35/GC212
 Completed – Streamlined BSC in the Porter Building. Location 35/2B410